Neural Circuits, Kinetics and Energetics HTS of Human iPSC-Neurons, -Microglia, and -Astrocytes: AI-Enabled Platform for Target ID, and Drug Discovery and Toxicity (e.g., Cancer Chemo & HIV ARTs)

Neurotoxicity is among the most common reasons for failure of drugs during clinical trials, illustrating that current
preclinical test models, which feature whole animals or animal cells are extremely poor at predicting human
neurotoxicity. Additionally, many currently FDA-approved therapeutics, such as anti-cancer chemotherapeutics,
are neurotoxic, which limits their therapeutic dosage and often results in impaired cognition during and after
treatment. FDA “black box” warnings, describing neurological side-effects, are common and currently prescribed
therapeutics for AIDs may contribute to HIV-Associated Neurocognitive Disorder (HAND). Accordingly, Vala
Sciences Inc., proposes a Fast-Track SBIR project to develop an assay system utilizing neurons, astrocytes,
and microglia, derived from human induced pluripotent stem cells (hiPSC-neurons/astrocytes/microglia) to test
candidate therapeutics for neurotoxicity. The cells will be cultured in 384-well dishes to enable high throughput
multiplexed assay of compound effects on neuronal activity (via Kinetic Image Cytometry [KIC] –
acquisition/analysis of videos of cells labeled with calcium and voltage indicators), and synapses, mitochondria,
endoplasmic reticulum, and cell viability. Since the assay will feature human cells, it will likely be more predictive
of human neurotoxicity vs. animal test systems currently used in preclinical research. Phase I activities will
develop the multiplexed system, to enable testing of compounds for toxic effects on mechanisms of action (MOA)
including alteration of plasma membrane ion channels, ER function and integrity, mitochondrial function, and
neuronal circuitry (correlated activity of neurons within a culture well). A total of 30 compounds with known MOA
and effects of humans, will be tested in Phase I, these data will be used to train artificial intelligence (AI) clustering
algorithms to recognize the MoAs, particularly for low doses of the test agents. The compounds will also be
tested on hiPSC-neurons/astrocytes/microglia representing APOE-3/4 and APOE-4/4 genotypes, as the
APOE-4 is associated increased neurotoxicity. In Phase II a total of 350 probes/drugs (of which 275 are known
to have clinical effects, and 75 will be expected to have no effect) will be screened, with the results used to
further train the AI and improve the overall clinical predictivity. Additional versions of the assay will be developed
featuring mutations/genotypes relevant to Alzheimer’s Disease and Bipolar Disease. In addition to recognition
of neurotoxicity, the assay system also will increase our understanding of neuronal circuits, which is responsive
to the BRAIN Initiative program. The neurotoxicity assay will be marketed to pharmaceutical companies
developing therapeutics across a broad spectrum of diseases/afflictions, including chemotherapeutics and
potential therapeutics for neurodegenerative diseases.

Public health relevance
An ongoing problem in drug development is that many therapeutics have side effects on the brain; for example, certain anti-cancer agents cause impairments in thinking (“chemofog”) which often persist following cessation of the cancer therapy, and medications used to treat AIDs may also impair thinking. Pharmaceutical companies currently test potential therapeutics for toxicity to the nervous system on animals (e.g., mice, and dogs), but harmful effects to the human nervous system are often first revealed in human clinical trials. Our project will develop a novel system to test candidate therapeutics for toxic effects on neurons derived from human adult stem cells (human embyos are not harmed in the preparation of the stem cells) which will be more predictive than animals, improve the efficiency and effectiveness of drug development, and reduce the use of animals in preclinical research.